Pediatric Heart Network Emory University

PROJECT SUMMARY
The mission of the Pediatric Heart Network (PHN) is to improve the health of children and adults with
structural congenital heart defects, as well as children with acquired heart disease through multi-center
clinical research. The Emory University Clinical Research Center combines the strengths and experience of
Children's Healthcare of Atlanta, the Sibley Heart Center, the Emory Adult Congenital Heart Center, and
Emory University School of Medicine with the goal of participating in a cooperative and interactive manner
with the other Clinical Research Centers, the NHLBI, and the DCC to carry out the mission of the PHN. The
specific aims of the Emory Clinical Research Center are 1) to participate as a core site in multi-center
studies evaluating medical, interventional and surgical therapies related to pediatric heart diseases and
congenital heart diseases across the lifespan, 2) to provide a training platform for fellows, junior faculty,
and nurses, 3) to support the development of novel techniques and methodologies, and 4) to promote
dissemination of study results to improve the scientific basis for the care of affected individuals. To
achieve these aims, the Emory site will propose and lead novel scientific trials and studies, take advantage
of its database and registry resources to enhance clinical studies, utilize the unique expertise of key
personnel with database and registry linkage and be an active contributor to PHN leadership via participation
in PHN committees and writing groups. The experienced team of clinician researchers and dedicated
research coordinators has a history of successful enrollment in difficult trials, timely data submission and
active participation in data analysis and dissemination of results. The Emory Clinical Research Center brings
special strengths to the PHN, including a high clinical volume of children with heart disease and adults with
congenital heart disease drawn from demographically diverse population. Collectively, these contributions
will ensure the success of the PHN.
In order to improve the lives of children with heart disease and adults with congenital heart disease, it is
necessary that cardiac programs work together to study the most important questions. The PHN provides
the best opportunity to answer these questions and promote evidence based medicine for the care of
affected individuals. The investigators of the Emory University Clinical Research Center have the
experience, skills and desire to support the mission of the PHN and successfully carryout these vital clinical
trials.

Public health relevance
The Emory University Clinical Research Center will carry out the mission of Pediatric Heart Network to improve health outcomes in patients with pediatric acquired and pediatric and adult congenital heart disease (CHD). This will be achieved by supporting research trials in these populations and communicating the findings to patients, families and care providers.